Creating an efficient clinical trial build system via the Clinical Trials Rapid Activation Consortium (CTRAC)

ABSTRACT Scientific Rationale. Childhood cancer survivors (CCS) represent a vulnerable population at high risk of medical and psychosocial sequelae of cancer and cancer treatment necessitating survivorship care supported by Children’s Oncology Group (COG) long-term follow-up guidelines. However, current data indicate that most CCS are not receiving recommended survivorship care. To date, approaches to identify receipt of guideline- concordant care fail to routinely include community and organizational factors that may influence receipt of this care. There is a critical need to develop an approach to identify receipt of guideline-concordant care in real time, incorporating CCS-generated and community and organizational-level data to explore disparities in care and ultimately support future interventions targeting the sources of those disparities. Hypothesis. We hypothesize that development of an electronic health record (EHR)-based CCS registry supplemented with patient-generated data will (1) be feasible and acceptable to CCS, (2) provide actionable identification of CCS not receiving guideline-concordant care, and (3) enable assessment of community and organizational factors associated with receipt of guideline-concordant care. Project Design. In Aim 1, our multi-disciplinary research team will draft CCS data elements to incorporate into our existing EHR-based cancer registry system, Healthy Planet (Epic Systems?). We will emphasize data elements that are not traditionally part of EHR-registries including community (e.g., neighborhood social cohesion, Area Deprivation Index) and organization factors (e.g., availability/efficacy of pediatric-to-adult care transition visits for CCS, barriers to survivorship care plan development or access). A CCS Advisory Board (n = 6-10 adult CCS or parents of CCS <18 years of age) will then review the proposed data elements over the course of 2-3 Advisory Board meetings, driving iterative revision of registry elements. Aim 2 will recruit 30 adult CCS from the EHR-based registry to input patient-generated data into the registry including self-reported community-level data and patient perspectives on organizational-level factors. Feasibility will be assessed through participation rate and data completeness. Acceptability of CCS-generated data will be assessed via participant surveys. For Aim 3, we will compare assessments of guideline-concordant care between traditional retrospective chart review and the new EHR-based registry. We will conduct exploratory analyses to assess whether community and organizational factors explain disparities in receipt of guideline-concordant care. Next Steps. Development of the proposed EHR-based registry is a necessary, first step toward the design of cancer center-level interventions to eliminate disparities and improve CCS outcomes. Once sufficient data is available, we will perform definitive analyses to identify community and organization factors related to receipt of guideline-concordant care. Subsequently, we plan to develop and test cancer center-level interventions to target identified community and organizational factors contributing to disparities in care of CCS.

Public health relevance
PROJECT SUMMARY A critical need exists to develop an approach to identify receipt of guideline-concordant care for childhood cancer survivors (CCS) in real time, incorporating community and organizational level data to explore disparities in care and ultimately support future interventions targeting the sources of those disparities. To address this critical need, this study’s objective is to identify and incorporate patient-generated data, community and organizational factors into an existing electronic health record (EHR)-based registry and study registry feasibility, acceptability, and ability to identify CCS receipt of Children’s Oncology Group (COG) long- term follow-up guideline-concordant care. This EHR-based registry will allow us to study community and organizational factors contributing to disparities in CCS receipt of guideline-concordant care and to develop cancer-center interventions to improve CCS outcomes.